Studying alcohol-associated liver disease and its interaction with rs738409 variant in PNPLA3 in a liver culture model

PROJECT SUMMARY
Alcohol-associated liver disease (ALD), caused by excessive alcohol consumption, is a growing public health
problem with a significant impact on the global population. In the United States, ALD is now a cause of rising
liver-related mortality, especially among younger patients.
Despite this severity, there are currently no FDA-approved therapies. The absence of consensus on
optimal drug targets or strategies underscores gaps in our mechanistic understanding of disease drivers.
While animal models have greatly contributed to our understanding of ALD pathogenesis, their utility and
clinical relevance remain a subject of debate. To enhance diagnostic capabilities and advance effective
therapeutics, it is imperative to establish reliable human-relevant models that mimic the liver's response to
disease-specific challenges. The increasing number of genetic variants associated with ALD susceptibility
further underscores the necessity for human-relevant systems.
To address these limitations, we devised a human induced pluripotent stem cell (hiPSC)-derived model
for ALD research, capitalizing on a multicellular in vitro liver culture system recently pioneered in our lab.
Within this multicellular setup, we co-cultivated hiPSC-derived hepatocytes, macrophages, and hepatic
stellate cells (HSCs), mirroring the intricate dynamics of liver physiology in both health and disease. Our
investigations unveiled that subjecting the liver culture to clinically relevant blood-alcohol concentrations
successfully replicated many pivotal alcohol (EtOH)-induced and endotoxin (i.e., LPS)-mediated ALD features.
Deeper scrutiny of hepatocytes over time revealed a macrophage-mediated upregulation of hepatic progenitor
markers, a dedifferentiation phenotype frequently observed in ALD patients. Furthermore, the liver cultures
exhibited a heightened reaction to EtOH/LPS than EtOH or LPS alone, especially in terms of HSC activation.
Subsequent investigation unveiled that EtOH exposure sensitized HSCs to LPS stimulation and TGFβ-
induced activation, revealing a previously unexplored mechanism underlying ALD pathogenesis.
Across three aims, employing cell and molecular approaches, we capitalize on the unique features of
this platform to address questions that cannot be sufficiently explored through existing ex vivo human-relevant
systems. We focus on our working hypothesis, postulating that activated macrophages induce hepatocyte
dedifferentiation through the secretion of soluble factors (Aim 1), and that EtOH exposure elicits changes in
specific genes and pathways, contributing to the heightened sensitivity of HSCs to LPS and TGFβ (Aim 2).
Aim 3 seeks to unravel the roles of a genetic risk factor (i.e., rs738409 C>G variant in PNPLA3), in ALD
development. These efforts will pave the way for more precise therapeutic interventions and targeted
treatments. A better comprehension of the genetic influencers of ALD risk has the potential to enhance the
identification of at-risk populations and fortify disease prevention strategies.

Public health relevance
PROJECT NARRATIVE Alcohol-associated liver disease (ALD), caused by excessive alcohol consumption, is a cause of rising liver- related mortality in the United States, yet we lack even one approved therapy. We propose an innovative platform to explore fundamental aspects of ALD pathogenies, the contribution of gut endotoxins, and understand how a genetic risk factor influences disease development and progression. These studies will provide new insights to inform development of effective diagnostics and treatments that can improve the lives of both patients and those at risk.